Pharmacodynamically directed targeted therapy for leukemia

PROJECT SUMMARY
Acute Myeloid Leukemia (AML) is both the most common and deadliest adult leukemia. Even with the best
therapeutic approaches the majority of AML patients relapse and die of their disease. Our central hypothesis is
that the inability to therapeutically impact AML outcome is derived from the similarity of these tumor cells to
normal hematopoietic stem cells and that both the disease and current therapies utilized to treat it are profoundly
immunosuppressive. As a team (Ohio State and the University of Cincinnati), we have moved toward developing
therapeutics that differentiate AML cells further from normal hematopoietic stem cells while at the same time
enhance immune activation. We have chosen to therapeutically target DHODH, a mitochondrial localized
enzyme that performs a rate limiting step in pyrimidine synthesis. Inhibition of DHODH with small molecules has
been shown to promote AML differentiation via induction of replicative stress and to activate the innate immune
system. Recent data generated by our group demonstrates DHODHi also mediates death in AML cells via
induction of ferroptosis. Using multiple in vivo models of AML, we have demonstrated DHODHi synergizes with
a wide range of currently used targeted therapies. Notably, we demonstrate significant synergy of DHODHi with
decitabine in TP53 mutated AML, the most lethal subset of this disease for which overall survival is poor.
We recognize prior limitations of potent DHODH inhibitor trials including 1) lack of patent protection to enable
effective drug development, 2) treatment related toxicity 3) ineffective pharmacodynamic (PD) markers to predict
adverse events, and 4) no strategy to mitigate adverse events. We have systemically addressed each limitation
with the pre-clinical development of our lead compound, HOSU-53. Improvements with our program include 1)
world-wide composition of matter patent protection, 2) optimization of a PD blood marker (dihydroorotate, DHO)
that defines tolerable versus toxic levels of DHODH inhibition, 3) delineation of a mechanism of cell death
(ferroptosis) that can be monitored in vivo and 4) strong pre-clinical data to support development of combination
approaches of HOSU-53 with decitabine. Having completed IND enabling studies with HOSU-53, we anticipate
this molecule will enter phase 1 testing as early as the 1st quarter of 2025. This proposal seeks support for
implementation of the first in human clinical trial with HOSU-53 in AML utilizing corresponding pharmacokinetic
and pharmacodynamic monitoring along with novel single cell DNA sequencing to monitor for elimination of
specific clones of AML eradicated by this treatment. Following completion of this phase 1 trial, we seek to perform
a phase 1b/2 study of HOSU-53 given together with decitabine in previously untreated TP53 mutated AML.
At completion of this project, we will have transitioned the potent DHODH inhibitor HOSU-53 to the clinic and
established a pharmacodynamically-informed dose. By utilizing single cell DNA sequencing to examine efficacy
in intra-patient clones of AML, we will also enable targeting specific molecular subsets of AML in future studies.
Finally, we will have completed a phase 1b/2 trial of HOSU-53 in previously untreated TP53 mutated AML.

Public health relevance
PROJECT NARRATIVE Potent targeting of pyrimidine synthesis by DHODH inhibition represents a vulnerability to acute myeloid leukemia (AML) and enhances decitabine efficacy in TP53 mutated AML. This proposal seeks to translate this effort with a potent DHODHi (HOSU-53) utilizing a novel clinical trial design, detailed pharmacokinetics, pharmacodynamics and intra-tumor response assessment with single cell DNA sequencing to monitor for clone elimination in patients with AML followed by a combination trial with HOSU-53 + decitabine in TP53 mutated AML.